Influence of aromatase on neuromuscular plasticity resulting from testosterone plus locomotor training after spinal cord injury

The motor dysfunction resulting from spinal cord injury (SCI) is precipitated by the neural insult and is
exacerbated by other factors that hinder motoneuron survival and muscle recovery, including disuse and low
testosterone (T). The success of bodyweight-supported treadmill training (BWSTT) diminishes as the SCI
severity worsens. We have developed a novel strategy involving BWSTT with adjuvant T-enanthate (TE) drug
treatment that promotes use-dependent neuroplasticity, in-part, by preserving white matter at the spinal lesion
and by supporting motoneuron survival, which stimulates neuromuscular recovery. However, the
supraphysiologic TE dose we used produced prostate enlargement in our rodent severe contusion SCI model,
which limits translation. The purpose of this proposal is to improve the translational applicability of BWSTT+TE
by identifying the lowest TE dose that enhances BWSTT-mediated neuromotor improvement, in an effort to
limit prostate growth and other androgenic side-effects. Secondly, we will determine the influence of estradiol
(E2) on BWSTT-mediated locomotor recovery and neuromuscular plasticity. The latter remains important from
translational and mechanistic perspectives because (1) T is converted to E2, via aromatase, within the central
nervous system and (2) E2 treatment produces potent neuroprotection in rats after SCI. To provide
comprehensive evidence of neuroplasticity, we will evaluate functional adaptations in our rodent SCI model in
response to the proposed treatments and assess anatomical changes that occur at the spinal cord lesion and
distal to the lesion, and in spinal motoneurons and muscle. To support this proposal, we have established a
male rodent severe mid-thoracic contusion SCI model that exhibits persistent hindlimb paralysis and
progressive muscle decline and 50% lower circulating T than non-SCI animals, similar to the T deficiency
present in nearly all men after SCI. Our data indicate that BWSTT+TE restored hindlimb overground walking
after severe SCI more so than BWSTT (alone) or TE (alone). Moreover, BWSTT+TE improved recovery of
muscle fiber cross-sectional area (fCSA), muscle force output, and prevented the deleterious slow (oxidative)
to fast (glycolytic) fiber-type transition in muscle. In Aim 1, we will perform a dose-optimization experiment to
identify the lowest effective TE dose and we will build upon our original data by comprehensively evaluating
locomotor recovery and neuromuscular plasticity in response to BWSTT+TE. The primary outcomes are open-
field locomotor recovery, soleus muscle function, soleus fCSA and fiber type distribution. In Experiment 1a,
SCI animals will remain untreated (vehicle) or will receive BWSTT with low, moderate, or high-dose TE, with
the lowest effective dose advancing. In Experiment 1b, SCI animals will receive vehicle, BWSTT, TE, or
BWSTT+TE. Aim 2 will then determine the influence of estradiol (E2) on BWSTT-mediated locomotor recovery
and neuromuscular plasticity. In Experiment 2a, SCI rats will receive vehicle, BWSTT, BWSTT+AN (aromatase
inhibitor that blocks conversion of T to E2), BWSTT+TE, or BWSTT+TE+AN. Experiment 2b will be a dose-
optimization study to identify the lowest E2 dose that enhances BWSTT-mediated neuromotor improvement.
SCI animals will receive vehicle or BWSTT with low-, moderate-, or high-dose E2. Experiment 2c will be a
comparative efficacy study in which SCI animals will receive vehicle, BWSTT or E2 (alone and in combination),
or BWSTT+TE. We hypothesize that the functional and anatomical measures of neuromuscular plasticity will
be most evident in SCI animals receiving BWSTT+TE, that E2 partially mediates neuromuscular plasticity
resulting from BWSTT+TE, and that more robust neuromotor improvement will occur in response to
BWSTT+TE versus BSWTT+E2. We anticipate that these experiments will provide the necessary data to
establish preclinical proof-of-principle for our multimodal therapy. If successful, this will set the stage for
translation of our preclinical findings to future clinical trials intended to hasten locomotor recovery and improve
neuromuscular function in Veterans with SCI.

Public health relevance
290,000 individuals have a spinal cord injury (SCI) in the US. Of these, ~42,000 are eligible for treatment in the Veteran Health System. Walking impairment is a hallmark consequence of SCI. We have developed a novel multimodal therapy combining body-weight supported treadmill training and testosterone therapy and have promising preclinical evidence that demonstrates greater walking recovery than either treatment alone following severe SCI. However, the dose of testosterone exceeds a clinical dose and if awarded, this Career Development Award, will identify the lowest effective testosterone dose that produces comprehensive functional gains in an effort to limit prostate growth when used in combination with body-weight supported treadmill training. Secondly, we will evaluate hormonal mechanisms underlying this promising novel therapy to obtain the data necessary to support future clinical trials that will assess the efficacy of our multimodal therapy intended to hasten locomotor recovery and improve neuromuscular function in Veterans with SCI.